Indigenous Pathways of Substance Use Risk and Resilience across Three Generations

PROJECT SUMMARY/ABSTRACT
Alcohol and other drug use inequities have had devastating impacts for many American Indian/First
Nations (Indigenous) communities and families. Social Determinants of Health (SDH) are critical
mechanisms of risk and resilience for substance abuse (SA), substance use disorders (SUD), and recovery
from SUD. This project will move beyond “risk-factor” epidemiology that largely ignores heterogeneity of SU
patterns and impacts of SDH and has failed to materialize into substantial changes in population health
outcomes. We will focus on identifying what matters most and to whom by examining relative impacts of SDH
for SA over the life-course and across generations of Indigenous families.
This competitive renewal application builds on our existing community-based participatory research with 8
tribal communities. We propose to continue computer-assisted survey interviews with existing Healing
Pathways “target participants” (baseline N = 735) for whom we already have 11 waves of developmental data
spanning childhood and early adulthood. We will enroll their own children in the study for multiple generations
of epidemiological information on SA, SUD, recovery and resilience. We will also collect qualitative information
to capture nuanced community perspectives on the contexts and mechanisms of substance use.
Results of this research will increase awareness of the nature, etiology, and consequences of
alcohol and other drug use problems and recovery in Indigenous reservation/reserve communities.
Another outcome is enhanced precision in identifying SDH related to substance use and positive
Indigenous development. Thus, the results of this project have potential to optimize the timing of
and targets of intervention and prevention programs and policies in Indigenous communities.

Public health relevance
PROJECT NARRATIVE This research addresses critical public health inequities related to alcohol and drug use within American Indian and First Nations (Indigenous) communities. We will identify diverse patterns and social determinants of substance use and recovery across 3 generations of Indigenous families with special attention to processes of recovery and resilience. Results will include precise targets for substance use prevention, intervention and policy to be shared with community stakeholders across the 8-participating reservation/reserves with an ultimate goal of reducing health inequities.